Unraveling Neural Diversity: Decoding the Cellular and Molecular Mechanisms of Neural Circuit Formation and Function in the Drosophila Central Complex

Summary:
A key question in neurobiology is how neural stem cells (NSCs) produce the vast diversity of neural
subtypes required for precise control of behavior. The human cortex is generated from a specialized
population of outer radial glia NSCs (oRGs) in the outer subventricular zone, which divide to produce
intermediate neural progenitors (INPs) that themselves divide to produce 8-12 neurons. Drosophila Type
II NSCs (T2 NSCs) divide in a similar pattern and generate INPs to produce most neural cells of the central
complex (CX)— a conserved brain region across insect species involved in producing complex high-level
behavior. Thus, T2 NSCs are a good model for investigating the genetic mechanisms of neural diversity
adopted by neural progenitors across species. We previously discovered a series of transcription factors
(TFs) and RNA-binding proteins (RBPs) that are sequentially expressed in T2 NSCs and INPs over
developmental time. These are ideal candidates for specifying the identity of the CX lineages through
combinatorial temporal patterning. Here, using an innate goal-directed behavior in flies— odor-guided food
search—associated CX circuit, we will identify which temporally expressed TFs and RBPs play a role in
specifying olfactory navigation circuitry and determine the role of these genes in specifying the number,
morphology, and identity of each circuit element (Aim 1). Next, we will use genetic birthdating to determine
the lineage and birthtime of each circuit element and to examine the link between birth timing and function
in a single T2 NSC lineage—DL1 (Aim 2). Finally, our proposed training, mentoring, and science outreach
activities through the Pueblo Brain Science program in New Mexico will target trainees at multiple levels
and will improve science education awareness and promote diversity in neuroscience (Aim 3). While
investigating mechanisms regulating neural diversity, our long-term goal is to make the neuroscience field
diverse through training, mentoring, and promoting science education in resource-limited and historically
neglected Pueblo communities. As many of the identified factors have human homologs, our results will
identify conserved principles governing the development of CX and provide insights into the development
of the human cortex.

Public health relevance
Narrative: Proper brain function depends on the precise number and type of neurons formed during development, with disturbances in genetic programs leading to severe neurological disorders. Our proposal uses Drosophila neural stem cells that are similar to human outer radial glia to unravel the mechanisms regulating neural diversity while training diverse next-generation neuroscientists. Given the high conservation of neural stem cells, genes, and behaviors we study, our work will provide novel insights into human brain development and disorders and advance our ability to harness stem cells to replace cells lost to injury or disease.